Data Core

ABSTRACT
The Data Management and Integration Core (DMIC) of the Kaposi Sarcoma (KS) in Era of Antiretroviral
Therapy in Africa Program (KEAAP) is responsible for streamlining and coordinating data management,
analytical procedures, statistical analysis, and bio-specimen storage and inventory in support of the research
activities proposed by the KEAAP pilot and research projects. The DMIC will perform its responsibility in close
collaboration with the Administrative Core and Career Developmental Core, and KEAAP investigators to
ensure efficient protocol adherence and consistent application of high quality control, biosafety and data
security practices. The DMIC will play a critical role in achieving KEAPP research objectives, and in supporting
other funded projects and new initiatives thematically related to the KEAAP, as well as in the training of
students, fellows, and new investigators within this HIV-associated malignancies program. The objective of
DMIC is to develop advanced biostatistics and epidemiology capabilities at the Tanzania and Zambia
partnering sites, through a shared and coordinated data collection system, with data integration from the
existing research and clinical informatics resources at the three partner institutions to support the three
proposed research project and other pilot projects. This will be achieved by the completion of three aims: 1)
Provide biostatistics and bioinformatics solutions, expertise and support services for the design and conduct of
KEAAP research projects in the areas of clinical, and laboratory studies and experiments. 2) Create
standardized operating procedures, databases, and data collection tools to ensure quality standards
throughout the 5-year study period for all KEAAP project arms. 3) Provide support and training to the KEAAP
consortium. The DMIC will work with KEAAP investigators in designing, testing, and implementing online data
collection tools and study databases using REDCap™ (Research Electronic Data Capture) to meet the specific
needs of the investigators. The DMIC will perform all statistical analysis, and work with investigators in
preparing presentations, manuscripts and progress reports. The DMIC will train and oversee personnel at each
institution on data entry placing special emphasis on data integrity, security and confidentiality. Additional
workshops will be conducted to increase capacity and shared knowledge across countries of the most up-to
date advances in data management, sharing and software. Activities of the DMIC will facilitate the sharing of
research findings and data among projects, increase collaborations between the researchers, and promote the
development of new research proposals, thereby integrating the knowledge acquired.

Public health relevance
NARRATIVE The KEAAP Data Management and Integration Core (DMIC) will establish an inter-institutional network providing study databases, biostatistics and epidemiology expertise, training, and technology support. The DMIC will work across the scientific spectrum from biology, biochemistry, and immunology to implementation science and clinical connection to support and accelerate translational research by KEAAP investigators. The DMIC is responsible for streamlining and coordinating data management, analytical procedures, statistical analysis, and biospecimen storage in support of clinical research proposed by the KEAAP research projects and pilot projects.